CE25-021 - Rise Up! A Youth-Informed Video Program To Prevent Community Violence Before The First Shot

ABSTRACT
Community gun violence (assault or homicide) is the leading cause of firearm injury and death in
urban youth in the United States, yet upstream primary prevention efforts are lacking.1-3 Risk factors for
community gun violence include aggression and violent conflict resolution, gun carrying, and living in socially
and economically disadvantaged neighborhoods with high prevalence of violence.27-30 Youth are not always
equipped to make smart or safe decisions regarding fighting, retaliation, and gun use. Additionally, they are
easily influenced by social perceptions regarding gun carrying, especially vulnerable in communities where
they could easily be victims of violence.20 Mentorship and conflict resolution skills for high-risk youth provided
by school-based or community violence interruption programs are effective at reducing community gun
violence; however, these services are limited resource-intensive.9-11,36,37 We propose development of a
video-based program (“Rise Up Against Gun Violence”) that is informed by youth ambassadors with
lived experience and leverages the expertise of violence interrupters to influence adolescents to avoid
risky behaviors that lead to community gun violence. The video topics and messaging will be developed
by the youth ambassadors and a multidisciplinary team of content experts, and refined through community
feedback. The series will focus on risk-reduction topics such as non-violent conflict resolution, avoiding
retaliation, and posting safely on social media, and will deliver hard facts about the dangers of firearm injuries
and other salient topics that youth identify. Our study design includes youth ambassadors and violence
interrupters from two cities with high levels of community gun violence (Houston and Memphis) to work with
experts to develop a series of videos. The video program intervention will be tested with youth cohorts
(community testers) in diverse settings in high-risk communities in both cities, and a mixed-methods approach
will assess attitude change about the consequences of gun carrying and use (primary outcome), behavior
change in gun carrying and fighting, increased awareness regarding risks of gun use, and establishment of
adult support (secondary outcomes). Our proposal is a novel and innovative, multi-faceted approach, a “plug-
and-play” program that could be disseminated to diverse community youth programs to utilize as part of their
programming to tackle primary prevention of the leading public health problem for American youth.

Public health relevance
NARRATIVE We propose development and effectiveness testing of a novel and innovative video-based program that will be informed by youth-for youth affected by gun violence that leverages the expertise and experience of violence interrupters and other violence content experts. The Rise Up Against Gun Violence! primary prevention program aims to influence at-risk adolescents in Houston and Memphis to avoid risky behaviors leading to community gun violence such as gun carrying and fighting. The program will be rigorously evaluated with youth cohorts in middle schools and community settings through a mixed-methods intervention approach to assess attitude and behavior changes regarding the consequences of gun carrying and gun use for violent conflict resolution.